Identifying molecular markers that predict relapse after therapy discontinuation in chronic myeloid leukemia.

The genome is relatively stable in chronic myeloid leukemia (CML), but mutation rates increase during
progression from chronic phase (CP) to blast crisis (BC). And, 30-50% of CML patients relapse in CP during
prolonged treatment with inhibitors of the Bcr-abl tyrosine kinase (TKIs). Relapse usually involves point mutations
in the BCRABL oncogene that impair TKI sensitivity, but many patients achieve remission after switching TKI.
Generation of reactive oxygen species (ROS) is relatively high in CML bone marrow, suggesting efficient ROS
handling may be required for low mutation rates in CP-CML during remission. CML neutrophils (PMNs) may
contribute to bone marrow ROS via the phagocyte-specific NADPH oxidase; activated during the innate immune
response. Consistent with this, we found aberrant activation of innate immune response pathways in human and
murine CML, and emergency (stress) granulopoiesis (EG) was sustained in CML mice. Failure to efficiently
terminate EG may favor mutagenesis by enhancing ROS production by CML-PMNs and expansion of leukemia
stem cells (LSCs) during this process. In a murine model of CML, we found that episodes of EG accelerated
TKI-resistance and BC compared to steady state. Oxr1 is the major mechanism for detoxifying PMN-ROS. Oxr1
has low (Oxr1S) and high efficiency (Oxr1L) isoforms. We found switch from Oxr1L to Oxr1S during EG in CML
mice but not Wt controls. Oxr1L also increased in CP relapse. Oxr1-knockdown in the bone marrow of CML mice
accelerated TKI-resistance and BC, consistent with a functional role for Oxr1 in leukemogenesis.
Half of CML patients with a sustained major molecular response to TKI-treatment (<0.01% IS) remain in
remission after TKI-discontinuation. Unfortunately, molecular markers to predict relapse vs sustained therapy
free remission (TFR) are unknown. During the current funding period, we performed single cell RNA-Seq on
CD34+CD38- cells from a CML patient cohort undergoing therapy discontinuation. We identified interaction of
αβT cells and CML-LSCs in patients with relapse post TKI-discontinuation and in our murine CML model. T cell/
LSC interaction was not found with sustained TFR, or in second remission after failed discontinuation. T cell
interaction with CML cells were not previously described, but interaction with αβT cells facilitates intercellular
pathogen killing by phagocytes during the innate immune response. We found TFR was prolonged in mice
transplanted with single LSCs vs αβT cell/LSC doublets, or by treatment with an αβT cell antibody. These results
suggest a functional contribution of these T cells to LSC persistence and relapse post TKI-discontinuation.
We hypothesize that dysregulation of the innate immune response in CML facilitates mutations that lead to
relapse or BC progression via inadequate ROS-handling and/or aberrant interaction of αβT cells with CML-LSCs.
The corollary to this hypothesis is that exposure of CML subjects to infectious challenge may enhance the risk
of mutagenesis or failed TKI-discontinuation. We will investigate this through 2 independent Aims;
Aim 1: Define mechanisms for impaired Oxr1 activity and detoxification of PMN-generated ROS in
CML-LSCs. We will use a murine CML model with Oxr1 knockdown to determine the impact of impaired ROS
handling on CP relapse and/or BC. Molecular mechanisms regulating and consequent to these events will be
investigated. Results will inform mechanistic studies in human Lin-CD34+CD38- CML cells.
Aim 2: Define mechanisms for CML-LSC/αβT cell interaction to induce LSC expansion and relapse
during TKI-therapy or after discontinuation. We will use a murine CML model to investigate mechanisms for
αβT cell interaction to induce LSC persistence and short TFR. Contribution to TKI-resistance will also be
investigated. Molecular characteristics of LSCs that interact with T cells, and T cells that interact with LSCs, will
be defined. Results will inform studies of T cell/LSC interactions in human Lin-CD34+CD38- CML cells.
Our goal is to define the role of aberrant activation of the innate immune response in CML progression and
identify possible molecular markers or therapeutic targets to decrease progression during or after TKI therapy.

Public health relevance
The genome is stable in chronic myeloid leukemia (CML) compared to other myeloid malignancies, permitting long-term successful treatment with tyrosine kinase inhibitors (TKIs). However, with progression to blast crisis (BC), genomic instability increases. Also, ~50% of CML patients develop mutations in the CML-specific BCRABL oncogene that lead to TKI-resistance. We found aberrant activation of the innate immune response in human subjects and a murine model of CML. We also found enhanced reactive oxygen species production with efficient detoxification in CML until TKI-resistance or BC develop. The first goal of these studies is to determine the role of immune dysregulation in disease progression in CML. 50% of CML patients with a sustained, major molecular response to TKIs remain in remission after stopping these agents. Current clinical tools do not define who will relapse, but we found that interaction of CML cells with αβT cells predicted relapse after TKI-discontinuation. Our second goal is to determine if this interaction enhances leukemia cell persistence during TKI-treatment.